Characterizing respiratory exacerbations in primary ciliary dyskinesia

ABSTRACT
Primary ciliary dyskinesia (PCD) is a rare, genetically heterogeneous, orphan disease characterized by pro-
gressive upper and lower respiratory tract infections and inflammation. Similar to other suppurative lung dis-
eases, people with primary ciliary dyskinesia experience episodic, acute respiratory exacerbations, clinically
characterized by increasing productive cough, fever and fatigue, that are typically treated with antibiotics and
increased airway clearance. Acute respiratory exacerbations cause significant morbidity and substantial health
care utilization, school or work absenteeism, and in some suppurative airway diseases accelerate structural
airway damage and airway obstruction. Given their negative impact on the lives of people with primary ciliary
dyskinesia, exacerbations have been targets for interventional trials designed to establish evidence-based guide-
lines for their prevention and treatment. However, the infectious precipitants that likely cause acute respiratory
exacerbations are frequently undefined and could be important factors for clinical trials. This ancillary study will
involve subjects with primary ciliary dyskinesia already enrolled in an NIH-funded parent longitudinal study
RDCRN Protocol 5907) that is designed to define the key characteristics of respiratory exacerbations and eval-
uate potential predictors and time to first exacerbations. The first Specific Aim will examine molecular approaches
to detection of viruses and bacteria in patients with PCD to define the baseline microbial state and the microbial
phenotype of respiratory exacerbations, using assays that can be performed on self-collected samples obtained
in the home, which will test two complementary hypotheses, that the microbial phenotype of a baseline sputum
sample can predict the frequency and severity of acute respiratory tract illnesses, and the microbial phenotype
of a sputum sample obtained during an ARI can predict the severity of the episode. In the second Aim 2, we will
use nasal gene expression profiles to characterize host response to acute respiratory tract illnesses, testing the
hypothesis that assessment of the host response will distinguish between viral infections with and without clinical
manifestations. This ancillary study that will enhance the parent project by further refining the characterization of
respiratory tract exacerbations, and establish the feasibility of microbial phenotyping of subjects at baseline and
during exacerbations on respiratory samples collected at home. We will examine the feasibility of microbial phe-
notyping of subjects at baseline and during exacerbations, thus determining the role of infectious precipitants
and inflammatory responses during respiratory tract exacerbations. Specifically, it will provide a highly detailed
characterization of the bacteria and viruses causing acute exacerbations in the PCD population, providing pilot
data that will better define respiratory tract exacerbations as a key endpoint for future clinical trials.

Public health relevance
NARRATIVE People with primary ciliary dyskinesia experience episodic, acute respiratory exacerbations that can accelerate structural airway damage and airway obstruction. In this study, we will examine the clinical significance of viral infection during exacerbations and determine their effect on host gene expression and bacterial composition, which will allow us to better define exacerbation phenotypes, creating more precise endpoints for clinical trials in PCD.